Structure-Function Relationship of Glycosaminoglycans

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text. Given the various tools that were developed to study Glycosaminoglycan (GAG) mixtures (specific aims 1), studying glycan mixtures in the context of glycans present in the upper airways became an obvious extension of this work. The glycan mixtures - especially the sialylated glycans present in the epithelial cells- provided the important reference point to these being critical receptors for Influenza A viruses. We had furthermore established a foundation to study the protein-GAG interactions, using various GAG degrading enzymes over the years. Based on the fact that many of these enzymes, and other GAG or glycan binding proteins, have poor sequence identity [this includes key sulfatases, fibroblast growth factors or influenza virus hemagglutinin (HA)], we developed newer tools to study GAG-protein interactions, which were broadly applicable to protein-glycan interactions. Newer analytical and structural tools were developed under specific aims 1 and as part of specific aims 2. We developed not only GAG/glycan databases, but also protein structural databases to study the diversity of glycan- protein interactions. Integration of these two approaches-glycan conformation coupled with protein structure and database-enabled us to tackle a fundamental question related to glycan specificity of influenza A viruses, which turned out to be the ideal model system to validate our approach. Given extensive glycan diversity and the mixture of glycans present in the apical epithelium, for the first time we demonstrated that glycan topology is a key determinant for human adaptation of influenza viruses (published in Nature Biotechnology). Our prediction that the then emerging 2009 H1N1 swine flu virus was not efficient in transmission (published in Science 2009) was further validated and observed due to poor transmission of this virus in humans (published in NEJM 2009). More recently, with the outbreak of the 2013 H7N9, we rapidly investigated the receptor specificity of the H7N9 HA and published our observations (along with our predictions on H5N1) back-to-back in the journal Cell. The R37 grant application will address key questions related to glycan topology and HA binding using complementary analytical and structural approaches.

Public health relevance
Influenza Viruses impact human health globally. Annually 5-15% of the global population is affected; 3-15 million people with serve illness due to influenza and 250,000 to 500,000 deaths have been reported. Annually, these viruses cost the United States $10 Billion and the total economic burden is about $100 Billion. PI: Ram Sasisekharan Grant No: R37GM057073 Bibliography ( highlighted (yellow) are selected publications funded by this R37 grant) 1 Gao, R., Cao, B., Hu, Y., Feng, Z., Wang, D., Hu, W., Chen, J., Jie, Z., Qiu, H., Xu, K., Xu, X., Lu, H., Zhu, W., Gao, Z., Xiang, N., Shen, Y., He, Z., Gu, Y., Zhang, Z., Yang, Y., Zhao, X., Zhou, L., Li, X., Zou, S., Zhang, Y., Yang, L., Guo, J., Dong, J., Li, Q., Dong, L., Zhu, Y., Bai, T., Wang, S., Hao, P., Yang, W., Han, J., Yu, H., Li, D., Gao, G. F., Wu, G., Wang, Y., Yuan, Z. and Shu, Y. (2013) Human infection with a novel avian-origin influenza A (H7N9) virus. The New England journal of medicine. 368, 1888-1897 2 Li, Q., Zhou, L., Zhou, M., Chen, Z., Li, F., Wu, H., Xiang, N., Chen, E., Tang, F., Wang, D., Meng, L., Hong, Z., Tu, W., Cao, Y., Li, L., Ding, F., Liu, B., Wang, M., Xie, R., Gao, R., Li, X., Bai, T., Zou, S., He, J., Hu, J., Xu, Y., Chai, C., Wang, S., Gao, Y., Jin, L., Zhang, Y., Luo, H., Yu, H., Gao, L., Pang, X., Liu, G., Shu, Y., Yang, W., Uyeki, T. M., Wang, Y., Wu, F. and Feng, Z. (2013) Preliminary Report: Epidemiology of the Avian Influenza A (H7N9) Outbreak in China. The New England journal of medicine 3 Kwon, T. Y., Lee, S. S., Kim, C. Y., Shin, J. Y., Sunwoo, S. Y. and Lyoo, Y. S. (2011) Genetic characterization of H7N2 influenza virus isolated from pigs. Vet Microbiol. 153, 393-397 4 Hirst, M., Astell, C. R., Griffith, M., Coughlin, S. M., Moksa, M., Zeng, T., Smailus, D. E., Holt, R. A., Jones, S., Marra, M. A., Petric, M., Krajden, M., Lawrence, D., Mak, A., Chow, R., Skowronski, D. M., Tweed, S. A., Goh, S., Brunham, R. C., Robinson, J., Bowes, V., Sojonky, K., Byrne, S. K., Li, Y., Kobasa, D., Booth, T. and Paetzel, M. (2004) Novel avian influenza H7N3 strain outbreak, British Columbia. Emerging infectious diseases. 10, 2192- 2195 5 Fouchier, R. A., Schneeberger, P. M., Rozendaal, F. W., Broekman, J. M., Kemink, S. A., Munster, V., Kuiken, T., Rimmelzwaan, G. F., Schutten, M., Van Doornum, G. J., Koch, G., Bosman, A., Koopmans, M. and Osterhaus, A. D. (2004) Avian influenza A virus (H7N7) associated with human conjunctivitis and a fatal case of acute respiratory distress syndrome. Proc Natl Acad Sci U S A. 101, 1356-1361 6 Zhu, H., Wang, D., Kelvin, D. J., Li, L., Zheng, Z., Yoon, S.-W., Wong, S. S., Farooqui, A., Wang, J., Banner, D., Chen, R., Zheng, R., Zhou, J., Zhang, Y., Hong, W., Dong, W., Cai, Q., Roehrl, M. H. A., Huang, S. S. H., Kelvin, A. A., Yao, T., Zhou, B., Chen, X., Leung, G. M., Poon, L. L. M., Webster, R. G., Webby, R. J., Peiris, J. S. M., Guan, Y. and Shu, Y. (2013) Infectivity, Transmission, and Pathology of Human H7N9 Influenza in Ferrets and Pigs. Science. Published Online May 23 2013, DOI:10.1126/science.1239844 7 Couch, R. B., Decker, W. K., Utama, B., Atmar, R. L., Nino, D., Feng, J. Q., Halpert, M. M. and Air, G. M. (2012) Evaluations for in vitro correlates of immunogenicity of inactivated influenza a H5, H7 and H9 vaccines in humans. PloS one. 7, e50830 8 Cox, R. J., Madhun, A. S., Hauge, S., Sjursen, H., Major, D., Kuhne, M., Hoschler, K., Saville, M., Vogel, F. R., Barclay, W., Donatelli, I., Zambon, M., Wood, J. and Haaheim, L. R. (2009) A phase I clinical trial of a PER.C6 cell grown influenza H7 virus vaccine. Vaccine. 27, 1889-1897 9 Tharakaraman, K., Jayaraman, A., Raman, R., Viswanathan, K., Stebbins, N. W., Johnson, D., Shriver, Z., Sasisekharan, V. and Sasisekharan, R. (2013) Glycan Receptor Binding of the Influenza A Virus H7N9 Hemagglutinin. Cell. http://dx.doi.org/10.1016/j.cell.2013.05.034 10 Yang, Z. Y., Wei, C. J., Kong, W. P., Wu, L., Xu, L., Smith, D. F. and Nabel, G. J. (2007) Immunization by avian h5 influenza hemagglutinin mutants with altered receptor binding specificity. Science. 317, 825-828 11 Tharakaraman, K., Raman, R., Viswanathan, K., Stebbins, N. W., Jayaraman, A., Krishnan, A., Sasisekharan, V. and Sasisekharan, R. (2013) Structural Determinants for Naturally Evolving H5N1 Hemagglutinin to Switch its Receptor Specificity. Cell. http://dx.doi.org/10.1016/j.cell.2013.05.035 12 Maines, T. R., Jayaraman, A., Belser, J. A., Wadford, D. A., Pappas, C., Zeng, H., Gustin, K. M., Pearce, M. B., Viswanathan, K., Shriver, Z. H., Raman, R., Cox, N. J., Sasisekharan, R., Katz, J. M. and Tumpey, T. M. (2009) Transmission and pathogenesis of swine-origin 2009 A(H1N1) influenza viruses in ferrets and mice. Science. 325, 484-487 PI: Ram Sasisekharan Grant No: R37GM057073 13 Garten, R. J., Davis, C. T., Russell, C. A., Shu, B., Lindstrom, S., Balish, A., Sessions, W. M., Xu, X., Skepner, E., Deyde, V., Okomo-Adhiambo, M., Gubareva, L., Barnes, J., Smith, C. B., Emery, S. L., Hillman, M. J., Rivailler, P., Smagala, J., de Graaf, M., Burke, D. F., Fouchier, R. A., Pappas, C., Alpuche-Aranda, C. M., Lopez-Gatell, H., Olivera, H., Lopez, I., Myers, C. A., Faix, D., Blair, P. J., Yu, C., Keene, K. M., Dotson, P. D., Jr., Boxrud, D., Sambol, A. R., Abid, S. H., St George, K., Bannerman, T., Moore, A. L., Stringer, D. J., Blevins, P., Demmler-Harrison, G. J., Ginsberg, M., Kriner, P., Waterman, S., Smole, S., Guevara, H. F., Belongia, E. A., Clark, P. A., Beatrice, S. T., Donis, R., Katz, J., Finelli, L., Bridges, C. B., Shaw, M., Jernigan, D. B., Uyeki, T. M., Smith, D. J., Klimov, A. I. and Cox, N. J. (2009) Antigenic and genetic characteristics of swine-origin 2009 A(H1N1) influenza viruses circulating in humans. Science. 325, 197-201 14 Fraser, C., Donnelly, C. A., Cauchemez, S., Hanage, W. P., Van Kerkhove, M. D., Hollingsworth, T. D., Griffin, J., Baggaley, R. F., Jenkins, H. E., Lyons, E. J., Jombart, T., Hinsley, W. R., Grassly, N. C., Balloux, F., Ghani, A. C., Ferguson, N. M., Rambaut, A., Pybus, O. G., Lopez-Gatell, H., Apluche-Aranda, C. M., Chapela, I. B., Zavala, E. P., Guevara, D. M., Checchi, F., Garcia, E., Hugonnet, S. and Roth, C. (2009) Pandemic Potential of a Strain of Influenza A (H1N1) : Early Findings. Science. 324, 1557-61 15 Wu, S., Wu, F. and He, J. (2013) Emerging risk of H7N9 influenza in China. Lancet. 381, 1539-1540 16 (2013) Novel influenza A(H7N9) virus linked to human disease in China, April 2013. Euro surveillance : bulletin Europeen sur les maladies transmissibles. European communicable disease bulletin. 18 17 Neumann, G., Chen, H., Gao, G. F., Shu, Y. and Kawaoka, Y. (2010) H5N1 influenza viruses: outbreaks and biological properties. Cell Res. 20, 51-61 18 Taubenberger, J. K. and Morens, D. M. (2008) The pathology of influenza virus infections. Annu Rev Pathol. 3, 499-522 19 Belser, J. A., Blixt, O., Chen, L. M., Pappas, C., Maines, T. R., Van Hoeven, N., Donis, R., Busch, J., McBride, R., Paulson, J. C., Katz, J. M. and Tumpey, T. M. (2008) Contemporary North American influenza H7 viruses possess human receptor specificity: Implications for virus transmissibility. Proc Natl Acad Sci U S A. 105, 7558-7563 20 Kimble, J. B., Sorrell, E., Shao, H., Martin, P. L. and Perez, D. R. (2011) Compatibility of H9N2 avian influenza surface genes and 2009 pandemic H1N1 internal genes for transmission in the ferret model. Proceedings of the National Academy of Sciences of the United States of America. 108, 12084-12088 21 Sorrell, E. M., Wan, H., Araya, Y., Song, H. and Perez, D. R. (2009) Minimal molecular constraints for respiratory droplet transmission of an avian-human H9N2 influenza A virus. Proceedings of the National Academy of Sciences of the United States of America. 106, 7565-7570 22 Skehel, J. J. and Wiley, D. C. (2000) Receptor binding and membrane fusion in virus entry: the influenza hemagglutinin. Annu Rev Biochem. 69, 531-569 23 Russell, R. J., Stevens, D. J., Haire, L. F., Gamblin, S. J. and Skehel, J. J. (2006) Avian and human receptor binding by hemagglutinins of influenza A viruses. Glycoconj J. 23, 85- 92 24 Stevens, J., Blixt, O., Paulson, J. C. and Wilson, I. A. (2006) Glycan microarray technologies: tools to survey host specificity of influenza viruses. Nat Rev Microbiol. 4, 857- 864 25 Shriver, Z., Raman, R., Viswanathan, K. and Sasisekharan, R. (2009) Context-specific target definition in influenza a virus hemagglutinin-glycan receptor interactions. Chem Biol. 16, 803-814 26 Van Hoeven, N., Pappas, C., Belser, J. A., Maines, T. R., Zeng, H., Garcia-Sastre, A., Sasisekharan, R., Katz, J. M. and Tumpey, T. M. (2009) Human HA and polymerase subunit PB2 proteins confer transmission of an avian influenza virus through the air. Proc Natl Acad Sci U S A. 106, 3366-3371 27 Tumpey, T. M., Maines, T. R., Van Hoeven, N., Glaser, L., Solorzano, A., Pappas, C., Cox, N. J., Swayne, D. E., Palese, P., Katz, J. M. and Garcia-Sastre, A. (2007) A two-amino acid PI: Ram Sasisekharan Grant No: R37GM057073 change in the hemagglutinin of the 1918 influenza virus abolishes transmission. Science. 315, 655-659 28 Srinivasan, A., Viswanathan, K., Raman, R., Chandrasekaran, A., Raguram, S., Tumpey, T. M., Sasisekharan, V. and Sasisekharan, R. (2008) Quantitative biochemical rationale for differences in transmissibility of 1918 pandemic influenza A viruses. Proc Natl Acad Sci U S A. 105, 2800-2805 29 Pappas, C., Viswanathan, K., Chandrasekaran, A., Raman, R., Katz, J. M., Sasisekharan, R. and Tumpey, T. M. (2010) Receptor specificity and transmission of H2N2 subtype viruses isolated from the pandemic of 1957. PLoS One. 5, e11158 30 Viswanathan, K., Koh, X., Chandrasekaran, A., Pappas, C., Raman, R., Srinivasan, A., Shriver, Z., Tumpey, T. M. and Sasisekharan, R. (2010) Determinants of Glycan Receptor Specificity of H2N2 Influenza A Virus Hemagglutinin. PLoS One. 5, e13768 31 Jayaraman, A., Pappas, C., Raman, R., Belser, J. A., Viswanathan, K., Shriver, Z., Tumpey, T. M. and Sasisekharan, R. (2011) A single base-pair change in 2009 H1N1 hemagglutinin increases human receptor affinity and leads to efficient airborne viral transmission in ferrets. PloS one. 6, e17616 32 Matrosovich, M. N., Matrosovich, T. Y., Gray, T., Roberts, N. A. and Klenk, H. D. (2004) Human and avian influenza viruses target different cell types in cultures of human airway epithelium. Proc Natl Acad Sci U S A. 101, 4620-4624 33 Nicholls, J. M., Bourne, A. J., Chen, H., Guan, Y. and Peiris, J. S. (2007) Sialic acid receptor detection in the human respiratory tract: evidence for widespread distribution of potential binding sites for human and avian influenza viruses. Respir Res. 8, 73 34 Soundararajan, V., Zheng, S., Patel, N., Warnock, K., Raman, R., Wilson, I. A., Raguram, S., Sasisekharan, V. and Sasisekharan, R. (2011) Networks link antigenic and receptor- binding sites of influenza hemagglutinin: Mechanistic insight into fitter strain propagation. Sci. Rep. 1, 200 35 Wang, C. C., Chen, J. R., Tseng, Y. C., Hsu, C. H., Hung, Y. F., Chen, S. W., Chen, C. M., Khoo, K. H., Cheng, T. J., Cheng, Y. S., Jan, J. T., Wu, C. Y., Ma, C. and Wong, C. H. (2009) Glycans on influenza hemagglutinin affect receptor binding and immune response. Proc Natl Acad Sci U S A. 106, 18137-18142